CONVERSION FROM STANDARD ANTI-EPILEPTIC DRUG TO GABAPENTIN MONOTHERAPY

The purpose of this study is to evaluate the dose response and efficacy characteristics of Gabapentin in patients with complex partial seizures by conversion from standard anti-epileptic medications to lose dose, medium dose, or high dose Gabapentin